Organ Specific Project

ABSTRACT: Organ Specific Project
Beyond nutrient absorption, the gastrointestinal tract has wide-ranging effects on the normal and
diseased physiologies of other organ systems, including metabolism, neural function, and the
immune system. A high-resolution, multi-modal 3D map of the bowel would be an invaluable
resource to understand normal bowel function and the perturbations that lead to disease. Our
continued goal is to create this map along the length of the small bowel and colon, both of which
have nuanced geographic specializations of function. Using single-nuclei RNA+ATAC-seq, we
will simultaneously profile the gene expression and regulatory programs that define the complex
cell populations that drive bowel function. We will use the CODEX multiplex immunoassay to
define the spatial relationships of these cell populations and to create 3D maps using serial
sections. We will also use the Molecular Cartography multiplex FISH assay to generate
transcript spatial maps to better integrate the single-nuclei data to the CODEX immuno-maps.
These investigations will be performed on tissues that are preserved and procured in a manner
suitable for high-quality molecular map generation. Our target milestone is to characterize six
bowel sites from a total of 8 demographically-diverse individuals at full coverage. To generate
deeper coverage maps in more individuals, two bowel sites will be mapped at light coverage in
20 individuals.